STRUCTURAL STUDIES OF MECHANISM OF MUSCLE CONTRACTION &ITS CONTROL

My laboratory studies the molecular mechanism of muscle contraction and its control using neutron and X-ray scattering and diffraction. In order to understand results from these experiments we do extensive model building using available data from crystallography and high-resolution electron microscopy. These modeling studies are greatly aided by the availability of the sophisticated facilities available in the Computer Graphics Laboratory. These facilities allow visualization of results of calculations and manipulation of high resolution information to allow further experimental design and hypothesis generation. We have used the CGL and newly solved structures of monomeric actin and myosin head (S1) to aid in our studies of F-actin and Acto-S1 structures using electron microscopy and crystallographic results. We also use the CGL to aid in interpreting neutron and X-ray scattering data using these crystallographic structures and the derived higher-order structures. In addition, we used the CGL to digitize electron density maps of the myosin head from electron microscopy.